PHYSIOLOGICAL SYSTEM IDENTIFICATION WITH THE KALMAN FILTER IN DOT

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Diffuse optical tomography (DOT) is a noninvasive imaging technology that is sensitive to local concentration changes in oxy- and deoxyhemoglobin. When applied to functional neuroimaging, NIRS DOT measures hemodynamics in the scalp and brain that reflect competing metabolic demands and cardiovascular dynamics. The diffuse nature of near-infrared photon migration in tissue and the multitude of physiological systems that affect hemodynamics motivate the use of anatomical and physiological models to improve estimates of the functional hemodynamic response. We have developed a linear state- space model for NIRS analysis that models the physiological fluctuations present in the data with either static or dynamic estimation. The goal of this work is to improve statistical power in the estimation of stimulus evoked hemodynamic response.